Altered CD4+ T cell responses and resultant asthma following neonatal human metapneumovirus infection

Human metapneumovirus (HMPV) is a leading cause of lower respiratory tract infection in childhood and is
associated with increased morbidity and mortality in neonates and young infants. Additionally, young children
diagnosed with HMPV bronchiolitis are at increased risk of developing asthma, which is the most common
chronic condition of childhood. Asthma in childhood is largely mediated by a subset of CD4+ T cells, known as
Th2 cells, which contribute to mucus production, eosinophil recruitment, and airway hyperresponsiveness.
However, the mechanistic connection between early life viral infection and the subsequent development of Th2-
driven asthma is unknown, thus limiting therapeutic and preventative strategy development. One contributing
factor to the acute and long-term pathology of respiratory viral infection could be underlying differences in the
developing neonatal immune system. The neonatal immune system is regulated differently than adults, as
neonates generally mount anti-inflammatory and tolerogenic responses. Prior literature has also demonstrated
that neonatal CD4+ T cell differentiation tends to favor development of Th2 cells when compared to adults. We
developed a new neonatal HMPV mouse model to evaluate neonatal CD4+ T cell responses. Neonatal mice
infected with HMPV intranasally on day of life 4-6 mounted an increased Th2 response compared to adults, while
adult mice exhibited a robust antiviral Th1 CD4+ response. Moreover, Th2 cells generated following neonatal
infection persisted as tissue resident memory (TRM) cells. In a late re-challenge model, mice initially exposed to
HMPV as neonates mounted a strong Th2 response to re-infection in adulthood characterized by eosinophil
recruitment, mucus production, and airway hyperresponsiveness consistent with asthma. Using an adoptive
transfer model with neonatal recipients, our preliminary studies suggest that Th1 differentiation is extrinsically
suppressed by a lymphocyte population in the neonate, which we hypothesize to be regulatory T cells (Tregs).
Additionally, preliminary single cell RNA sequencing experiments suggest that neonatal CD4+ T cells use different
metabolic pathways compared to adults; cell metabolism has been connected to T cell differentiation. Collectively,
our preliminary data demonstrate that neonates mount a Th2-dominant response, exhibit increased Treg activity,
and demonstrate altered T cell metabolism compared to adults. The central hypothesis of this proposal is that
extrinsic suppression of Th1 differentiation by Tregs and intrinsic metabolic preferences promoting Th2 formation
lead to preferential differentiation of neonatal CD4+ T cells into Th2s that persist and contribute to asthma
pathogenesis. We propose three Specific Aims: 1) To evaluate tissue resident memory (TRM) CD4+ T cell
contributions to asthma pathology following neonatal HMPV infection; 2) To determine the role of regulatory T
cells in Th1 suppression in the neonatal lung following primary HMPV infection; and 3) To define the role of
altered neonatal CD4+ T cell metabolism on differentiation/skewing. This application is for administrative
supplement to support Dr. Eddens on the parent award described above (1K08AI182486-01).

Public health relevance
NARRATIVE Respiratory viral infections in neonates and infants are associated with increased acute morbidity and an increased long-term risk of developing asthma. This proposal aims to understand the unique intrinsic and extrinsic mediators of the altered CD4+ T cell response following human metapneumovirus infection in neonatal mice. Further, this proposal will evaluate the long-term effects of neonatal human metapneumovirus infection on formation of tissue resident memory cells and the role of these cells in asthma pathogenesis.